Effects of Physical Activities on Pain and Functional Recovery in Low Back Pain

Low back pain (LBP) is the #1 cause of disability worldwide and a leading cause among Veterans. LBP has a
recurrent course for most individuals, involving the periodic occurrence of new episodes that patients must
manage. New LBP episodes therefore are critical juncture points where interventions hold promise for
optimizing functional recovery, promoting return to work (RTW), and averting a cascade of downstream
consequences such as opioid use, mental health problems, and even the risk of suicide and death.
The general advice to remain active during a new LBP episode is a key part of clinical practice guidelines.
However, existing guidelines provide no specific recommendations about the types of activity (e.g., lifting,
bending, etc.) that should be engaged in or avoided (“Which?”) or the duration/intensity of such activities
should they be performed (“How?”). The guidelines therefore do not address a major concern of patients with
LBP, which is that certain activities may have short-term effects on pain exacerbations or “flares”, or cause
sustained detrimental effects on pain or function. The distinctions between healthy, benign, and detrimental
activities are also important to clinicians, who are often called upon to complete “work restriction forms” as part
of the RTW process. An ideal set of work restrictions after a new LBP episode would limit only those activities
that are likely to cause flares of pain (short-term effects) or poor overall functional recovery in the longer term
(overall effects). However, there exist no empirically derived data concerning the short-term vs. overall
effects of specific activities during a new episode of LBP, with which to guide work restrictions.
Instead, in standard practice, clinicians’ recommendations to engage in or avoid specific activities rely on their
personal practice style and may limit functional recovery if overly restrictive. The proposed research will use a
novel approach to distinguish the short-term effects of activities from the overall effects of such activities, by
conducting a longitudinal case-crossover study nested within a cohort study. This design accounts for
measured and unmeasured confounds by using each case as his/her own control, analogous to a crossover
experiment, capitalizing on modern mobile health and actigraphy technology.
Aim 1: Estimate the short-term effects (24 hours) of specific physical activities on pain flares in
Veterans with LBP. A longitudinal case-crossover study will be conducted to identify activities that trigger
flares among 550 Veterans of working age (18-65 yrs) seen for a new LBP episode in VA primary care. The
primary outcome is a validated flare definition characterized by pain and functional impact. Analyses will use a
biopsychosocial framework accounting for potential confounders and moderators, such as pain characteristics,
work-related factors, catastrophizing, fear of movement, depression, post-traumatic stress, and opioid use.
Aim 2: Estimate the overall effects of specific physical activities among Veterans with LBP. A cohort
study approach to the Aim 1 study sample will examine associations between the frequency of specific
activities over the first 8 weeks of follow-up, and overall LBP-related functional recovery as defined by the
Roland-Morris Disability Questionnaire at 12-month follow-up (primary outcome). Analyses will also use a
biopsychosocial framework accounting for a broad range of other factors, as done for Aim 1. Secondary
outcomes include average pain intensity, lost work productivity, quality of life, and opioid use at 12 months.
These study aims will produce the first evidence-based estimates of the short-term and overall risks of
activities during LBP. These data will (1) support Veterans with LBP in navigating the complex process of
recovery, (2) assist VA clinicians in providing work restrictions, and (3) inform the development of a future
educational intervention for LBP that can be tested in a future RCT. Thus, this work responds directly to the
Rehabilitation Research and Development service’s call for activity-based interventions for chronic pain.

Public health relevance
Low back pain (LBP) is second only to hearing problems as a reason for Veteran disability, and it is the most common cause of disability globally. Although general activity is encouraged in the treatment of LBP, there is very little information on the specific types of activities that are beneficial or harmful for patients seen in primary care for a new episode of LBP. We propose a study using innovative design and analysis methods, and modern mobile health and actigraphy technology, to identify the short-term and overall effects of different types of physical activities on LBP outcomes among Veterans in VA primary care. This work will provide completely new, foundational information that will support Veterans with LBP in navigating the complex process of recovery. It will also help VA doctors to make recommendations regarding return to work and activities for those with LBP. Our proposed research responds directly to the Rehabilitation Research and Development service’s call for research into activity-based treatments for chronic pain.